Oxylipins, aging and Alzheimer’s disease

Alzheimer’s disease (AD) comprises about two-thirds of the total dementia cases, and the number of AD cases
is expected to triple by 2050. Identifying a new pathway that modulates AD will not only improve our
understanding of the mechanism behind neurodegeneration, but will also significantly improve the quality of life
of the aged population. Recent human studies revealed a causal relationship between the levels of omega-3 and
omega-6 dietary lipids and aging of the brain. However, the specific pathway(s) behind such effects remains
largely unknown. The overall goal of this proposal is to elucidate the role of omega-3 and omega-6
polyunsaturated fatty acids (PUFAs) metabolites in AD. Metabolism of omega-3 and omega-6 PUFAs generates
hundreds of lipid-signaling molecules called oxylipins through the arachidonic acid (AA) cascade. These oxylipins
play a homeostatic role in inflammation, blood pressure regulation, angiogenesis, and fibrosis, and their in vivo
levels are significantly affected by disease progression. Furthermore, recent studies suggested that specific
oxylipins may play an important role in AD. The deposition of Aβ and tau are hallmarks of AD, and aging remains
one of the key risk factors of AD. Therefore, in this proposal, we hypothesize that deposition of Aβ and tau and
aging modulate the in vivo oxylipin levels, which affects the neuronal health of animals.
To test our hypothesis, we will develop a multidisciplinary approach by assembling expertise from organic and
analytical chemists, neurobiologists, AD researchers and the use of a model organism. We will 1) establish the
relationship between endogenous levels of CYP450 PUFA metabolites and the effect of Aβ-, tau-and aging-
induced neurodegeneration and; 2) determine the effect(s) of specific oxylipins on Aβ-, tau-and aging induced
neurodegeneration. We will use Caenorhabditis elegans (C. elegans) as a model organism to study the effect of
Aβ and tau, and aging on PUFA metabolism because of the ease of generating large age-synchronized
populations, and the number of established genetic tools available to carry out this research. Furthermore, many
aging and neurodegenerative pathways and oxylipin pathways are conserved between C. elegans and humans.
We will use state-of-the-art ultra-performance liquid chromatography coupled with tandem mass spectrometry to
determine oxylipins levels in C. elegans over the lifespan of the organism and in transgenic strains that
overexpress Aβ and tau. We will test the effect of oxylipins that are significantly affected by deposition of Aβ and
tau and aging in neurodegenerative assays using transgenic strains that overexpress Aβ and tau. Upon success
of this project, we could identify a new pathway important for aging and neurodegeneration research. Our results
could also explain the effect(s) of omega-3 and omega-6 PUFAs on aging.

Public health relevance
Project Narrative Our investigation of oxylipins and Aβ-, tau- and aging-induced neurodegeneration will lead to a better understanding of the role of the metabolism of dietary lipids in Alzheimer’s disease, which will help us to design a better diet to improve overall health and quality of life in humans. Specifically, we will use synthesized cytochrome P450 metabolites of dietary lipids as powerful chemical probes, state-of-the-art analytical tools, and a novel biological model to delineate the role(s) of oxylipins on Aβ-, tau- and aging-induced neurodegeneration. Our preliminary data and data from others suggest that these omega-3 and omega-6 fatty acid metabolites have significant effects on Alzheimer’s disease and because the levels of omega-3 and omega-6 fatty acid metabolites in our body are greatly affected by diet, our lifestyle, and environmental toxins, illustrating that lipid metabolism could have a major role in Alzheimer’s disease.